Role of Health Care in Addressing Unhealthy Alcohol Use and Disparities among Aging Women

ABSTRACT
Unhealthy alcohol use has increased significantly among aging women, raising their risk of serious alcohol
related adverse consequences. At the same time, they are less likely than men to access treatment, and this is
exacerbated among racial/ethnic minority women. Health care providers and systems will face an increasing
number of aging women with alcohol problems, often with co-occurring health conditions that would improve
with reduced drinking. Currently, there is limited research on the growing needs of this aging population,
including on how racial/ethnic minority women may be disproportionately impacted by unhealthy alcohol use
and on how to develop effective interventions. To understand these critical gaps and inform a holistic approach
to alcohol-related healthcare, we propose a mixed-method study of over one million (1,298,009) aging women
(≥age 50) in a diverse health care delivery system of over 4.5 million members. We leverage unique
longitudinal electronic health record (EHR) data from a universal alcohol screening program in primary care,
with an estimated 784,794 aging women regularly screened for unhealthy alcohol use at multiple primary care
visits between 2014-2022. We integrate screening data with a NIAAA-funded alcohol registry that contains
medical and psychiatric diagnoses, self-report health behaviors (e.g. tobacco, exercise, interpersonal violence
screening), and health service encounters across clinical settings. Our approach is guided by a conceptual
model that incorporates Intersectionality Theory and the Andersen’s Model of Health Services Utilization. We
first identify trends and predictors of unhealthy alcohol use (defined as exceeding guidelines or alcohol use
disorder) among aging women overall and by age and race/ethnicity. Second, we test whether health services
utilization (e.g., routine primary care visits, brief alcohol interventions, medications, and addiction and/or
psychiatry treatment) is associated with reductions in alcohol use over time among all aging women who report
unhealthy alcohol use and among subsets with co-occurring health conditions (e.g., chronic pain,
depression/anxiety, diabetes and hypertension) and medication use (e.g., opioids). Across each aim, we
examine racial/ethnic differences to identify potential disparities. We use advanced causal modeling
approaches to analyze hypothesized relationships, and to appropriately control for potential confounding and
biases. For a deeper understanding of these vulnerable patients’ needs and potential barriers to care, we
conduct qualitative interviews with aging women who report unhealthy alcohol use and with providers who care
for them in different medical settings (e.g. primary care, geriatrics, addiction medicine), which we triangulate
with the quantitative data. Findings will provide urgently needed evidence on how health services can impact
unhealthy alcohol use, so that health care systems can better identify and treat this vulnerable population
through targeted interventions.

Public health relevance
PROJECT NARRATIVE This timely study examines trends and predictors of unhealthy alcohol use among aging women (≥ age 50) in a large, diverse health care system, and how health services can reduce unhealthy use, with a particular focus on potential disparities for racial/ethnic minority women. We also interview patients, and providers who care for them, to gain a deeper understanding of aging women’s needs, and potential treatment strategies. Findings will inform how health systems can address unhealthy alcohol use among aging women, a critical growing clinical and public health problem.